Nutrient signaling at ER-Mitochondrial contacts and age-related mitochondrial dysfunction

Project Summary
Altered mitochondrial function, a hallmark of aging, contributes to age-related diseases, in part, due to energetic
failure. Maintenance of mitochondrial energetics requires proper fission and fusion that are in turn regulated by
proteins at endoplasmic reticulum-mitochondria contacts (a.k.a. mitochondria-associated membranes or MAMs).
Fasting stimulates mitochondrial fatty acid utilization, and it is thought that the benefits of fasting are due to
adaptive changes in mitochondrial dynamics and respiration. How fasting impacts mitochondrial dynamics and
MAMs in intact mammalian systems, and whether these fundamental mechanisms are altered with age and
dietary stress remain unknown. The mechanisms by which upstream signaling cascades regulate mitochondrial
dynamics is becoming an area of great interest, with recent work showing AMPK as a regulator of fission. Our
new data show that the typically nutrient-responsive mTORC2 is paradoxically reactivated by fasting, and that
mTORC2 reactivation supports mitochondrial fission. Indeed, livers silenced for mTORC2 regulator Rictor show
impaired fission and dampened respiration; and mTORC2 activity is suppressed with age. These data raise a
key point: since clinically available mTOR inhibitors (e.g., rapamycin) block both mTORC1 and mTORC2, we
argue that benefits of long-term mTOR inhibition with rapamycin are counterbalanced by mitochondrial
dysfunction due to concomitant mTORC2 inhibition. This forms that basis to explore if blocking mTORC1—in
conjunction with maintaining mTORC2 activity—will lead to healthspan and lifespan extension. Phosphorylation
is a well-established signal in regulation of mitochondrial dynamics. Our phosphoproteomics data suggest that
paradoxical reactivation of mTORC2 kinase during fasting stimulates mitochondrial fission by phosphorylating
novel protein targets at MAMs, including NDRG1, N-Myc downstream regulated 1. Interestingly, the NDRG1S336A
phosphorylation-deficient mutant recapitulates the effects of loss of mTORC2 on mitochondrial
fission/respiration, while phosphomimetic NDRG1S336D stimulates mitochondrial fission. Intriguingly NDRG1, but
not the NDRG1S336A phosphorylation-deficient mutant, interacts with Cdc42, a cytokinetic protein with the intrinsic
GTP hydrolysis activity required for mitochondrial fission. Based on our preliminary data, we propose that
activation of the mTORC2-phosphorylated NDRG1Ser336-Cdc42 axis at MAMs regulates mitochondrial fission
during fasting, and that dysregulation of the mTORC2-NDRG1Ser336-Cdc42 axis leads to age-related loss of
mitochondrial fission and respiration. Three aims are proposed that will characterize (Aim 1) mitochondrial
dynamics and MAMs in aged and stressed livers; (Aim 2) determine if and how dysregulation of the mTORC2-
NDRG1Ser336-Cdc42 axis causes age-related loss of mitochondrial fission; and (Aim 3) explore if synergistic use
of rapamycin and co-expression of phosphomimetic NDRG1S336D will lead to greater lifespan extension when
compared to use of rapamycin alone. Experiments proposed here will rigorously test a new set of hypotheses
that altered mTORC2 signaling is a major contributing factor to age-related loss of mitochondrial function.

Public health relevance
Project Narrative Altered mitochondrial networking and energetics contributes to age-related diseases. Maintenance of mitochondrial networking is a function of the balance between rates of mitochondrial fission and fusion, which is, in turn, regulated by proteins localized at endoplasmic reticulum-mitochondria contacts or MAMs. Studies in this application will advance our understanding of the interplay between mTORC2 kinase and its downstream targets at MAMs in preventing age-related decline in mitochondrial fission and energetics.